Core B - Biomarkers Core

Project Summary/Abstract - Core B:
The goal of the Biomarkers Core (Core B) is to support Projects 1-3 and Core C in this P01 application by
providing bioanalytical support for a broad range of analytical and biochemical assays that address the
fundamental redox biology of the production of O2-/H2O2, hydroperoxide metabolism, and processing of redox
active metal ions relevant to the study of pharmacological ascorbate (P-AscH-) in preclinical models and
clinical trials. Core B will provide validated reagents, e.g. stock solutions of key reagents, standards,
Seahorse and EPR analyses, enzymological analyses, ionizing radiation services, and molecular biology
reagents, to Projects 1-3. Examples range from our unique, efficient, and cost-effective assays for determining
plasma ascorbate concentrations in patient-derived samples (Project 1 and Project 2) as well as assays for
ascorbate in the wide variety of samples generated in the proposed preclinical studies (Projects 1-3). Core B
has a large repertoire of assays that will examine the basic redox biology of P-AscH-. The leaders of the core
have also developed new unique assays and methods that are focused on addressing questions central to the
proposed clinical trials in this P01. The leaders have more than 30 years of experience in this field as well as
in directing University of Iowa core facilities in the Carver College of Medicine and the Holden Comprehensive
Cancer Center. Thus, they are well qualified to lead this core.

Public health relevance
Project Narrative - Core B: The Biomarkers Core will provide validated reagents and tools as well as state-of-the-art assays to probe the redox biology of pharmacological ascorbate as a potential adjuvant in cancer therapies. This support ranges from assays for ascorbate and markers of redox status in patient-derived samples to newly developed assays that quantitatively assess an array of biochemical markers/parameters in pre-clinical experiments.